The role of NPAS4 in drug addiction

Substance use disorder is a chronic, relapsing behavioral disorder that is characterized by compulsive drug
seeking and use despite negative consequences to the individual. During the course of drug use, there are
persistent neuroadaptations that occur in the nucleus accumbens (NAc), a brain region associated with reward
and motivation. This region is highly involved in drug reward sensitivity and learning, and dysregulation
contributes to multiple phases of addiction. For example, in abstinent addicts, relapse can be triggered by
environmental cues associated with previous drug use, but the molecular and cellular mechanisms underlying
relapse triggers are not well understood. One possible mechanism is that drug use activates specific populations
of neurons that are responsible for the association between reinforced behavior and drug-associated stimuli. Our
lab has previously shown that the epigenetic enzyme, histone deacetylase 5 (HDAC5), is critical for cocaine
reward-related learning and memory. We are currently testing the hypothesis that a transcription factor and
downstream target of HDAC5, neuronal PAS Domain Protein 4 (NPAS4), is involved in the formation of cocaine
reward-context memories through its function in a specific subpopulation of neurons in the NAc. NPAS4 is
induced rapidly and transiently by glutamatergic synaptic activity, and it regulates excitatory/inhibitory synapse
balance and synaptic transmission. NPAS4 also shapes neuronal circuits to encode learned information, and it
is induced strongly by exposure to novel drug contexts. The aims laid out in this proposal will determine the cell
type-specific role of NPAS4 in cocaine reward-context learning and memory, as well as the role of NPAS4-
inducing NAc neurons in the learned association between external cues and cocaine reward experiences. These
experiments employ a fusion of transgenic lines with cutting edge viral vector constructs to elucidate the role of
NPAS4 in the mechanisms behind drug addiction. All analyses will be performed in mouse models of contingent
and non-contingent drug reward learning. The Medical University of South Carolina is a leading center in the
substance abuse field and is an ideal location for performing these experiments. In addition, my mentorship
under Dr. Christopher Cowan will bolster my training in laboratory techniques, scholarship, career development,
and ethics, all of which are necessary for success in my predoctoral training and subsequent academic research
career. The comprehensive experimental design of these studies and rigorous application of pioneering
techniques will provide fundamental knowledge about the role of NPAS4 in the learning and memory of drug
reward and will provide significant learning and development opportunities that will serve as a foundation for my
future career in neuroscience.

Public health relevance
PROJECT NARRATIVE Substance use disorder an increasingly prevalent public health problem and, despite efforts to understand the neurocircuitry underlying drug abuse, effective treatments remain elusive. This proposal aims to provide a platform for understanding the neurobiological mechanisms underlying cocaine seeking, which could provide targets for the development of more effective pharmacotherapeutic interventions.